R, PILOT ASSESSMENT OF SE OF SELEGILINE TDS IN CHILDREN W/ AD/HD &TO

The purpose of this study is to evaluate the tolerability, safety, and effect- iveness of selegiline administered as a skin patch (STS) in children and adol;escents with ADHD and TS.